PediatRic sEpsiS induCed MODS: Relationship of Immune-phenotypes and antiBiotic Exposures (PRESCRIBE) study

PROJECT SUMMARY/ABSTRACT
Morbidity and mortality in children with sepsis and multi-organ dysfunction syndrome (MODS) are substantial.
Timely delivery of effective antibiotic concentrations to the site of infection dictates treatment outcomes, but
antibiotic pharmacokinetics (PK) are highly variable in septic children, frequently leading to sub- or supra-
therapeutic antibiotic concentrations. To ensure optimal clinical and microbiologic outcomes, attainment and
maintenance of safe and effective antibiotic concentrations throughout the treatment course are paramount.
Despite this, antibiotic dosing in children with sepsis is based primarily by a child’s weight and kidney function,
without regard to other sources of PK variability, while clinical measurement of antibiotic concentrations is
performed for very few drugs. The host response to infection is a major driver of organ dysfunction and
antibiotic PK variability in pediatric sepsis: hyperinflammation, as well as sepsis-induced immune dysfunction
(i.e. immunoparalysis), are both common and exacerbate outcomes. Further, in critically ill children with
respiratory failure, bacterial burden and composition of the respiratory tract microbiome impact both host
inflammation and clinical outcomes. Understanding how the host immune response, antibiotic PK, and the
microbiome interrelate, and influence clinical outcomes, is imperative to optimize treatment in pediatric sepsis.
The Collaborative Pediatric Critical Care Research Network (CPCCRN) will perform two concurrent, double-
blind, placebo-controlled RCTs to evaluate the impact of individualized immunomodulation (anakinra for
hyperinflammation; GM-CSF for immunoparalysis) on organ function outcomes in pediatric sepsis-induced
MODS. These trials (named PRECISE) provide a unique framework for evaluating the interplay between host
immunophenotype (hyperinflammation, immunoparalysis), immunomodulation, and antibiotic PK/PD through
our proposal. We will leverage PRECISE trials and CPCCRN infrastructure to evaluate sources of PK
variability in children with sepsis and MODS, investigate how host immune responses longitudinally modulate
antibiotic concentrations, and study how antibiotic concentrations impact organ dysfunction duration and the
respiratory tract microbiome. In Aim 1, we will determine the influence of host immunophenotype and response
to immunomodulation on antibiotic PK early (1A) and throughout the course (1B) of pediatric sepsis-induced
MODS. Aim 2 focuses on understanding how antibiotic concentrations impact organ function outcomes in the
context of immunomodulation in pediatric sepsis-induced MODS. Lastly, Aim 3 will quantify how antibiotic
concentrations, immunophenotype and immunomodulation impact the respiratory tract microbiome over time in
septic children with respiratory failure. By quantifying antibiotic concentrations and evaluating the drivers of
antibiotic PK in sepsis in the context of immunomodulation, our proposal will facilitate development of
individualized treatment strategies during sepsis-induced MODS.

Public health relevance
PROJECT NARRATIVE Children with sepsis and multi-organ dysfunction syndrome (MODS) demonstrate high morbidity and mortality. Successful treatment requires timely delivery of effective antibiotic concentrations to the site of infection, but in sepsis this is often impaired by an over- or under-active host immune response to infection. Within the context of two ongoing randomized trials being conducted within the Collaborative Pediatric Critical Care Research Network (CPCCRN), which will examine how modifying the host immune response to infection in children with sepsis and MODS impacts outcomes, our proposed research will study how the host immune response and organ dysfunction in sepsis influence antibiotic concentrations over time, and how both antibiotic concentrations and the host immune response impact clinical and microbiological outcomes.